Journey: NIDDK Short-term Education Program for Underrepresented Persons/Step-up

Project Summary/Abstract The American Indian Research and Education Center (AIREC) within the University of Nevada, Las Vegas (UNLV) under the School of Community Health Sciences, submit the Journey proposal in response to the National Institutes of Health, National Institute of Diabetes and Digestive and Kidney Disease (NIDDK), Short-Term Research Experience Program for Underrepresented Persons (STEP-UP), R25. AIREC's proposal warrants consideration for the Coordinating Center that encompasses the American Indian/Alaska Native (AI/AN) and Puerto Rican (PR) 11th & 12th grade high school students. Journey is an eight to ten week summer program which will expose twenty AI/AN and PR junior and senior high school students to the science of diabetes, endocrinology, metabolism, nutrition, and obesity. The long-term objective of Journey is to develop a sustainable research education program for high school students that provide hands on experiences with biomedical, behavioral, and clinical and social sciences research in diabetes, endocrinology, metabolism, nutrition, and obesity. Journey will give students direct exposure to mentors, research methods, skill building, and fellow researchers. This will result in the following measurable changes: • Increased knowledge of real-world use of scientific methods; • The role that research plays in shaping medical and behavioral fields; • Increased knowledge of responsible conduct in health-related research; • Increased knowledge of the role of research scientists and the diversity of people who pursue medical-science careers. Journey is designed to increase AI/AN and PR high school students' capacity and scientific knowledge in pursuing higher education degrees in the biomedical, behavioral, clinical and social sciences research fields.

Public health relevance
Project Narrative: The American Indian Research & Education Center's (AIREC) relevance of the proposed Journey: American Indian/Alaska Native & Puerto Rico Coordinating Center, High School NIDDK Short-Term Research Experience for Underrepresented Persons (STEP-UP )speaks to increasing and strengthening the shortage of American Indian/Alaska Natives (AI/AN) and Puerto Rican students pursuing the fields of biomedical, behavioral, and clinical research, in the areas of diabetes, endocrinology, metabolism, nutrition, and obesity. AIREC's ability to provide STEP-UP opportunities will increase high school AI/AN's and Puerto Rican students' capacity and scientific knowledge in order to pursue higher education degrees in the biomedical, behavioral, clinical and social sciences research fields.